Methods Core

We propose to expand the existing Mental Health Research Network (MHRN) to include 14 research centers
embedded in large health systems serving a combined population of over 25 million patients in 16 states.
MHRN infrastructure will be enhanced to support a next-generation research network, including:
• Expansion of data resources regarding patient-reported outcomes from real-world practice
• Development of new data resources in high-priority areas (e.g. perinatal exposures)
• A Scientific Analysis interest group to increase the rigor of analytic methods across MHRN projects
• Methods development focused on evaluation of adaptive treatment strategies for people with more severe
mental health conditions and on predictive analytic tools designed to address stakeholder priorities
This overall application requests support for an Administrative Core, a Methods core, two Signature research
projects and two Pilot research projects. The Methods Core will include an Informatics Unit, led by Drs.
Gregory Simon and Christine Stewart, and a Scientific Analysis Unit, led by Drs. Susan Shortreed and Patrick
Heagerty. The Informatics Unit will continue highly successful work over the past 8 years, supporting routine
data quality assessment and descriptive analyses of diagnosis and treatment patterns across all participating
health systems. New work will include development of tools and resources to assess and minimize privacy
risks when sharing sensitive health data for research and development of specific new data areas (perinatal
mental health and prenatal exposures, expanded list of patient-reported outcomes, and assessments of social
determinants of health). The Informatics Unit will provide consultation to all MHRN core and affiliated projects
and share all resources with other researchers and health systems via MHRN's public repository of
specifications, code lists, and analytic code. The Scientific Analysis Unit will support to all MHRN core and
affiliated projects via project-specific consultation and development of a learning community of analysts and
biostatisticians across MHRN research centers. This Unit will also focus on development and dissemination of
analytic methods in two areas directly relevant to MHRN research. Work on evaluating adaptive treatment
strategies will build on Dr. Shortreed's recently funded methods grant to evaluate and disseminate methods for
using health system data to tailor treatments for individuals with more chronic or severe mental health
conditions, focusing on assessing treatment effects when treatments are adjusted or switched according to
previous treatment failures or adverse effects. Work on stakeholder-driven predictive analytics will build on
MHRN's development of accurate suicide risk prediction models, focusing on matching specific study designs
and model development methods with stakeholder priorities and implementation constraints.